FIRST CRYSTAL STRUCTURE OF PROTEIN KINASE

The catalytic subunit of cAMP-dependent protein kinase represents the basic catalytic subunit that is conserved in every protein kinase and therefore, owing to the structural homology between protein kinases, may serve as a model for viewing the entire family of over one hundred protein kinases. Crystallization studies resulted in several different complexes in tow different space groups (P212121 and P6122). Structure solution of the catalytic subunit will be based on our best crystal, an orthorhombic crystal (P2121) of a binary complex of recombinant catalytic subunit with a specific 20-amino acid peptide inhibitor. A mercury derivative was used to identify two cysteine residues, Cys 199 and Cys 343. The "phasing power" (fr.m.s./Er.m.s.) of this derivative ranged from 3.13 to 1.91 within the resolution range of 10.15Angstrom to 3.61Angstrom. An electron density map to 2.7Angstrom resolution has been obtained by first generating a 3.5Angstrom resolution map using the B.C. Wang error filtering method and, second, resolution extension. The CdATP binding site was located using CdATP co-crystals of the ternary complex, with a specific peptide inhibitor. The identified ATP binding site appears in the immediate vicinity of Cys 199, as predicted from other biochemical studies. Within the elongated bilobal molecule, seven helices and nine beta-strands have been identified. Model building at the present stage consists of 90% alpha-carbons. Structure solution of the hexagonal crystal (P6122) of the pig heart catalytic subunit (myristic acid present) ternary complex with MgATP and a specific peptide inhibitor is based on the molecular envelope of the binary complex and the method of molecular replacement. The molecular orientation in the hexagonal unit cell was determined using the fast rotation function and data in the resolution range of 5.0Angstrom to 3.0Angstrom. The translational function applied to all Harker sections determined the molecular position and selected the correct space group. The real space orientation matrix is: 0.5331, -0.0356, 1.0000, 1.0504, - 0.0701 -0.0101, 0.0150, 0.2625, 0.0000 and the position of Hg-Cys 199 is: x= -0.082; y= -0.371; z= -0.033. This position corresponds to the position of Hg-Cys 199 x= 0.365, y= -0.133, z= 0.542 in the orthorhombic cell (P212121). Structure solution of two crystal forms will reveal not only the architecture of the catalytic subunit with and without myristic acid, but also the topology of the ATP and peptide binding sites. Furthermore, those structural studies will allow to proceed the crystallographic analysis of various mutants, the first of which has already been crystallized (Cys 343->Ser).